B cells for treatment of ARDS

Survivors of acute respiratory distress syndrome (ARDS) manifest pulmonary and neurological sequelae, as
clearly documented during the COVID-19 pandemic. The goal of this project is to ameliorate both pulmonary and
brain neuronal injury in ARDS and mitigate against long-term complications. Using a mouse model of hyperoxic
lung injury, we recently discovered that hyperoxia leads to a surprisingly profound depletion of pulmonary B cells,
with regulatory and memory B cell subsets being particularly vulnerable. B cell depletion has also been reported
in patients with ARDS. We aim to modulate inflammatory responses in ARDS by administering B cells that would
ameliorate this deficit and restore immune regulation. We now show that systemic administration of naïve B cells
has significant anti-inflammatory and tissue-protective effects in hyperoxic lung injury and that a fraction of these
B cells traffic to the lungs. Our central hypothesis is that adoptively transferred naïve B cells provide multiorgan
protection in hyperoxia-associated ARDS; we propose that this is achieved by trafficking to the sites of tissue
injury to restore immune regulation and suppress inflammatory responses in IL-10 and/or adenosine-dependent
manner. In Aim 1, we will study the efficiency of B cell homing to the lungs and brain and characterize the
phenotype(s) of B cells that home in these inflamed sites. In Aim 2, we will identify the immunomodulatory effects
of adoptively transferred B cells in the lungs and brain and study their dependence on B cell-derived non-Ig
factors including IL-10 and adenosine. In Aim 3, we will determine the effects of syngeneic and allogeneic B cell
therapy on long-term pulmonary and neurologic outcomes. Understanding long-term outcomes after allogeneic
B cell therapy will be critical for future translation of this therapy into clinical practice. The results of these
proposed experimental studies will direct our further research into B cell therapy for ARDS. Our studies may
have substantive translational impacts, in identifying novel therapeutic targets for treating patients with this highly
significant and increasingly common clinical problem.

Public health relevance
PROJECT NARRATIVE The recent COVID-19 pandemic highlighted the critical unmet need for effective treatments for acute respiratory distress syndrome (ARDS) that would mitigate not only against lung injury but also ARDS-associated brain injury. We will test a novel approach to treat both lung and brain injury in ARDS with intravenously administered naïve B cells. We propose that B cells migrate into the sites of injury where they suppress inflammation and promote healing.